ISU Bridges to Research Careers

Modified Project Summary/Abstract Section

Pathways to biomedical careers are exceptionally difficult for undergraduate students from across Idaho, and especially for first generation, limited income college students. Student learning and professional development researchers have identified a critical role for an open & welcoming research education community (REC) in the development of young scientists. The long-term goal of the proposed program is to help students gain necessary skills, embrace an identity as a scientist, join a community of scientists, and embark on a biomedical career. To accomplish this, the investigators will create the ISU Bridges to Research Careers (BRC) program. The objective of this grant is to create a pathway to biomedical careers for undergraduate students from throughout Idaho by interweaving a mentoring program for freshmen college students; a bacteriophage discovery & bioinformatics course developing biomedical research skills using an NIAID-relevant model system; and a biomedical research network that will provide authentic research opportunities for participants in labs conducting NIAID-relevant research. The proposed BRC program will effectively reach undergraduates early in their college career and guide them as they develop into scientists and embark on biomedical careers. The program efficiently leverages existing activities, providing tangible opportunities for Idahoans, preparing participants to meet our nation’s future biomedical research workforce needs. The BRC program also adheres to best practices for development of young scientists, creating an REC that facilitates the development of participant self-image as a scientist, enhances persistence, and prepares students for biomedical careers.

Public health relevance
Modified Public Health Relevance Section The proposed program is relevant to public health because it contributes to the development of scientific human resources that will ensure our Nation's capability to prevent disease by graduating students who embark on biomedical careers. The program is relevant to NIAID’s mission because it contributes to a highly trained and health-focused workforce by recruiting and preparing participants from across Idaho. Upon conclusion, the program will have trained dozens of participants who would likely have not completed college.